NEUROMUSCULAR DISORDERS IN HIV INFECTION AND ROLE OF AZT

This project is directed to investigation of the type and natural history of neuromuscular disorders and myopathies in HIV infection and the role of corticosteroids and AZT in their treatment.